De-Medicalizing PrEP by Partnering with House and Ball Community Using Social Work and Guiding Principles: Prioritizing Young Black LGBTQ+ Individuals

Abstract
The proposed study is aligned with the topic “
Equity-focused approaches to reduce HIV-related health
disparities” and
will address the `Prevent' pillar of the Ending the HIV Epidemic (EHE): A Plan for America.
Despite indications that new HIV infections in the United States are plateauing, young Black LGBTQ+ individuals
are disproportionately affected, for whom the rates of new infection continue to climb. Critical gaps in our
understanding of the barriers to successful pre-exposure prophylaxis (PrEP) engagement among this priority
group further hinders our ability to prevent HIV infections. The House & Ball Community (H&BC) has been
disproportionately affected by the HIV epidemic for decades. The H&BC provides a unique opportunity to apply
an equity-focused approach through meaningful partnership to enhance the PrEP care continuum to include
young Black LGBTQ+ individuals with lived experience. In addition, HIV/AIDS crosses all fields, including mental
health, addictions, community development, and health care. With their expertise in providing psychological and
environmental support as well as their case management skills in establishing service linkages and engaging in
client advocacy, social workers have been at the forefront of efforts to improve the lives of people infected and
affected by HIV disease. Social work practice in this area provides an opportunity to support young Black
LGBTQ+ individuals in partnership with the H&BC.
Using the Health Equity Implementation framework and the Community-Partnered Participatory Research
(CPPR) involving partnership between an academic institution (UCLA CHIPTS) and a community partner (the
AMAAD Institute), the proposed study will facilitate the involvement of a locally trusted social work provider
agency and a community health center to develop
and evaluate the effectiveness of non-medicalized social work
and community engagement strategies
. The proposed study will proceed in 3 phases over 2 years. The Specific
Aims of the proposed study are:
Aim 1: Examine barriers and challenges affecting the PrEP care continuum among young Black LGBTQ+
members of the House & Ball Community (H&BC);
Aim 2: Formalize H&BC empowerment services that facilitate linkages to support and retention services
provided at a comprehensive social work and grassroots engagement agency; and
Aim 3: Pilot test equity-focused, community-engaged grassroots model approaches that can support the PrEP
care continuum for young Black LGBTQ+ members of the H&BC.

Public health relevance
Public Health Relevance The proposed study focuses on the “ Equity-focused approaches to reduce HIV-related health disparities” and addresses the `Prevent' pillar of the Ending the HIV Epidemic (EHE): A Plan for America. Using the health equity implementation framework and the community-partnered participatory research, the proposed study will facilitate the involvement of a locally trusted social work provider agency and a community health center to develop and evaluate the effectiveness of non-medicalized social work and community engagement strategies. These strategies will support the engagement of young Black LGBTQ+ members of the House and Ball Community (H&BC) to optimize the pre-exposure prophylaxis (PrEP) care continuum.